Patient-centered and efficacious advance care planning in cancer: the PEACe comparative effectiveness trial

Abstract Summary:
Failure to deliver care near the end of life that reflects the needs, values and preferences of patients with
advanced cancer remains a key shortcoming of our cancer care delivery system. National organizations
including the National Academy of Medicine and American Society of Clinical Oncology have called for
increased attention to advance care planning (ACP) to improve patient-centered care near end of life. A critical
barrier to progress in the field is a lack of evidence about the most effective and efficient ACP strategy to
improve treatment decisions near end of life and ensure patients' wishes are honored.
Two different patient-facing ACP interventions are widely used and known to be effective but entail sizeable
differences in costs and complexity to deploy: (1) in-person discussions with trained facilitators and (2) web-
based advance care planning using interactive videos. These approaches have never been compared directly; it
is therefore unclear whether one form of ACP is more potent—and if so, for whom and under what
circumstances. Understanding the relative effectiveness of in-person, facilitated versus web-based ACP is
important because in-person ACP requires far more resources.
This proposal is a single-blind, patient-level randomized trial to address this evidence gap, using mixed
methods to compare the effectiveness of in-person, facilitated ACP vs web-based ACP among 400 patients with
advanced cancer and their family caregivers. Aim 1 compares the effect of these approaches on patient and
family caregiver outcomes (engagement in ACP—primary outcome; ACP discussions with family caregivers and
physicians; advance directive (AD) completion; and caregiver symptoms of depression and anxiety). For
patients who die during the study period, we will use validated, caregiver-reported measures to compare
perceived quality of EOL care, patients' EOL goal attainment, and bereaved caregiver symptoms of depression,
anxiety and post-traumatic stress. Aim 2 assesses implementation costs of each intervention and effects on
healthcare utilization at end of life. Aim 3 identifies contexts and mechanisms influencing the effectiveness of
each approach.
This trial will have a high impact because it will provide new and much-needed empirical evidence about two
patient-facing ACP approaches that successfully overcome limitations of traditional written advance directives
but entail very different investments of time and resources. It is innovative in using mixed methods to
evaluate not only the comparative effectiveness of these approaches, but also for whom, how and in what
circumstances they are effective. It is feasible because it builds on extensive infrastructure developed by an
accomplished research team with experience conducting behavioral intervention trials and qualitative research
in ACP and oncology.

Public health relevance
Project Narrative: The proposed project addresses a major public health problem that arises in the care of patients with incurable malignancies: failure to deliver end-of-life (EOL) care consistent with patients' needs, values and preferences. The purpose of this trial comparing the effectiveness of (1) in-person, facilitated advance care planning versus (2) web-based advance care planning is to identify the best approach to improve treatment decisions near EOL and ensure patients' wishes are honored. Data from this study will inform clinicians, payers and health systems seeking to adopt and scale the most effective and efficient ACP strategy in real-world oncology settings, with the potential to improve care for the over 600,000 Americans who die annually from cancer and their families. 3